ADMINISTRATIVE CORE

PROJECT SUMMARY (See instructions): The Administrative Core will review the activities of all the program projects and the Molecular and Transgenic Core in order to maximize success in achieving the scientific goals of this Program Project. The Core will be responsible for implementing timely changes in direction or fund utilization, and will help all the investigators with the managerial and secretarial work necessary for the success of the program. The Core will be directed by Bernardo Rudy, the Program Director and Principal Investigator of Project II. Mrs. Wendy Martinez will serve as Administrative Manager and will help the director in the implementation of the Core's functions. To accomplish its work, the Administrative Core will organize a monthly meeting of the Principal Investigators, a quarterly meeting of all the scientific and technical personnel of the PPG and an annual meeting with the External Advisory Board that will review and advice the whole program. Through these activities it will also contribute to the unifying aspect of this Program Project Grant.

Public health relevance
RELEVANCE (See instructions): The Administrative Core will oversee and provide all the necessary administrative support for the entire Program Project.